Regulation of canonical and non-canonical substrates of histone lysine methyltransferases

PROJECT SUMMARY
Protein lysine methylation is a post-translational modification (PTM) that neutralizes the positive charged
side chain and modulates protein functions in many key biological events. In metazoans, somatic cells displaying
distinct cellular phenotypes are originated from one zygote and contain the identical sequence of DNA. Upon
differentiation, transition of cell fate is initiated by lineage transcription factors and a cell identity is stabilized by
epigenetic factors that define a chromatin state. Distinct histone lysine methylation is central to active or
repressive chromatin formation. Dysregulation of this process often leads to pathogenic conditions such as
developmental disorders or cancer. Once an epigenetic state is established, cells need to faithfully recapitulate
the steady state in mitosis in order to safeguard cell identity and prevent developmental dysregulation and
oncogenic transformation. The epigenetic inheritance is a new research discipline undergoing rigorous
investigations. Despite that significant advancement has been achieved to decipher the mechanisms of
repressive chromatin inheritance, how active chromatin is inherited, involving temporo-spatial regulations of
histone lysine methyltransferases, still remains elusive. In addition to histones, histone lysine methyltransferases
also catalyze non-histone methylation events, whose importance is emerging in the context of early development.
However, there is a lack of systematic investigation of these non-canonical substrates and how they critically
regulate distinct biological processes. In this proposal, we will address these key knowledge gaps by
interrogating the mechanistic questions in active chromatin inheritance and develop a new approach to
investigate non-canonical methylation events by histone lysine methyltransferases. We expect to establish new
research platforms and advance our understanding towards methylation biology.

Public health relevance
PROJECT NARRATIVE Protein lysine methylation is instrumental to many key biological processes, in which histone lysine methyltransferases play pivotal roles to regulate key chromatin mechanisms. However, the non-canonical roles of histone lysine methyltransferases are emerging to regulate non-chromatin pathways in the context of development and cancer.